JHU Center for the Advancement of HIV Neurotherapeutics (JHU CAHN) - Biomarker Core

PROJECT SUMMARY - BIOMARKER CORE
The JHU Center for the Advancement of HIV Neurotherapeutics (JHU CAHN) will focus on a CNS complications
that commonly present in PWH based on the framework of the NIMH Research Domain Criteria (RDoC) that
classifies CNS complications based on dimensions of observable behavior and neurobiological measures that
include Negative and Positive Valence Systems (e.g., anhedonia, fear), Sensorimotor Systems, Systems for
Social Processes (e.g., social avoidance), Arousal/Regulatory Systems (e.g., sleep), and cognition. This
framework provides new opportunities to more accurately associate biomarkers with particular symptomology
with the goal of identifying molecular targets for the development of personalized medicine approaches by the
Therapeutics and Clinical Cores. The Biomarker Core will work closely with the Therapeutic and Clinical cores
to integrate multi-dimensional data and tools such as machine learning algorithms and offer these services to
investigators interested in NeuroHIV. Technical services will include mass spectrometry analysis for metabolites,
lipids, and proteins, multiplex Meso Scale discovery assays, extracellular vesicle isolation and cargo
characterization. Informatics analyses offered will include Small Molecules Pathway Database, Kyoto
Encyclopedia of Genes and Genomes, Cytoscape, and Ingenuity Pathway Analysis. Advanced non-parametric
analyses will include a variety of multivariate modeling such as principal component analysis (PCA), partial least
squares-discriminant analysis (PLS-DA), and sparse PLS-DA analysis, Significance analysis of metabolites
(SAM), and Empirical Bayesian analysis of metabolites (EBAM) models to identify features that discriminate
clinical biotypes or experimental groups. These services will be communicated broadly to the NeuroHIV
community through our multicenter weekly seminar series. These services are unique to the JHU CAHN, and
provide a valuable resource to NeuroHIV investigators at all stages of career development.